Genetic Discovery and Functional Validation to Identify Precursors of Clot Embolization in those with a Deep Vein Thrombosis

ABSTRACT
Venous thromboembolism (VTE) is a clinical condition that includes deep vein thrombosis (DVT), a clot in the
deep veins of the legs and pelvis, and pulmonary embolism (PE), a clot in the pulmonary arteries. Pulmonary
emboli are primarily a consequence of a dislodged DVT clot that travels from the deep veins to the lungs,
obstructing blood flow; they are too often fatal. The aim of this proposal is to identify genetic variation
associated with venous clot embolization to the lungs in those with a DVT and to characterize the biology and
pathology underlying this process. Little is known about factors associated with embolization, including genetic
factors, and the knowledge gap is wide. The only established genetic predictor of embolization is rs6025
variant in the coagulation factor V (FV) structural gene (F5); rs6025 has been shown repeatedly to be a
stronger predictor of DVTs without a PE (odds ratios [OR] ~4.8) than of DVTs with a PE (OR ~2.1). We know a
lot about the functional consequence of the F5 variant rs6025 on FV protein function, but our understanding
does not explain the differential DVT-PE effect. We have preliminary data indicating that another non-
synonymous F5 variant, rs4524—not in linkage disequilibrium with rs6025—is also differentially associated
with DVT-PE risk. Further, this differential in DVT-PE risk for the F5 variants is not observed for other well-
established VTE variants, including F2 (prothrombin) and ABO. No large-scale genetic discovery effort has
been undertaken to identify new loci differentially associated with DVT-PE risk, nor has a systematic
investigation of known loci been pursued to characterize the underlying biology. The aims of this proposal will
address these scientific gaps. The research settings are the International Network Against Venous Thrombosis
(INVENT) Consortium, which has amassed over 35,000 VTE cases from 15 studies with genome-wide
markers, and the Wolberg Laboratory at the University of North Carolina at Chapel Hill, which specializes in
mechanisms of clot formation, structure, and stability. There are 3 aims. Aim 1: VTE Sub-phenotyping: Using
existing study information on the classification of VTE, we will sub-phenotype 35,049 VTE cases to identify
those with DVT alone and those with PE, with or without a diagnosed DVT. Aim 2: Genetic Discovery: We will
then conduct a genome-wide association study meta-analysis that estimates the risk of PE among those with a
DVT. Agnostic and candidate-variant testing will be conducted. Replication will be conducted in over 12,000
VTE cases. Aim 3: Functional Biology: We will conduct functional interrogations of genes and their variants that
are known to be differentially associated with DVT-PE risk. Our approach will be to provide biologic evidence
from systematic and reductive, function-focused experiments. Initial work will focus on F5 rs6025 and rs4524;
subsequent work will interrogate other novel associations in functional assays of clot formation, structure, and
stability. This work will advance our biologic understanding of venous clot embolization to the lungs and may
present opportunities to reduce fatalities attributable to PE.

Public health relevance
NARRATIVE The aim of this proposal is to better understand why venous clots in the legs sometimes dislodge and travel to the lungs. These clots block circulation to the lungs and are life-threatening. We are interested in identifying inherited factors that lead to clots traveling to the lung and learning how the inherited factors change the biologic function that causes a clot to dislodge.